Multiparametric characterization of periodontal tissues for inflammation monitoring using quantitative ultrasound, texture analysis and machine learning

Project Summary/Abstract
Approximately 42% of adults in the U.S are affected by periodontal diseases. These diseases impose excessive
pain and systematic health issues on patients which even at their earliest stage negatively impact patients’
everyday quality of life. Patients can be characterized by periodontal diseases based on the presence of a
spectrum of oral inflammatory conditions, from gingivitis (i.e. early reversible inflammation) to periodontitis (i.e.
irreversible damages). The current standard method in clinics for assessment of these diseases is bleeding on
probing (BOP). BOP is invasive, subjective, semi-quantitative and a late indicator of disease progression. Thus,
there is an urgent clinical need for research on noninvasive quantitative techniques for detecting these diseases
for an improved diagnosis. To address this need, the current study centers around high-frequency
ultrasonography, a well-established diagnostic modality for various biological tissues but with limited applications
in periodontology. Our hypothesis is that quantitative parameters from ultrasound scan data and ultrasound
images can be employed to estimate the extent of periodontal inflammation. Here, we aim at establishing
ultrasound-derived quantitative biomarkers and a machine learning (ML) classifier for improved characterization
of the inflammatory condition in a pre-clinical, pre-existing cohort consisting of in vivo periodontal swine scans.
Our preliminary findings on quantitative ultrasound (QUS) analysis of two periodontal tissue types (gingivae and
alveolar mucosa) strongly suggest that ultrasound speckle statistics parameters have potential as a biomarker.
They discriminated tissues (>93%) with respect to histology as ground truth. Here, our proposed study will
include a comprehensive QUS investigation of tissue scan data (Specific Aim 1), texture analyses of ultrasound
B-mode images (Specific Aim 2) and a multiparametric ML classifier for periodontal inflammation classification
combining parameters from QUS and texture analysis (Specific Aim 3). In the first aim, we will investigate
longitudinal periodontal ultrasound data (baseline and inflammation) from ultrasound speckle models including
Homodyned-K, Burr and Nakagami. We will also assess the effect of periodontal inflammation on ultrasound
attenuation. In the second aim, we will conduct four types of texture analysis techniques on longitudinal
ultrasound images (image processing) including statistical and wavelet features to quantify the complex
underlying structure of periodontal tissues, as a more sophisticated approach than traditional B-mode
echogenicity analysis. We will assess the potential of each parameter as an individual inflammation biomarker.
In our third aim, we will quantitatively analyze histology images to find potential correlation between histology
parameters and QUS or texture parameters. Ultimately, we will perform a multiparametric analysis by building a
ML classifier based on combined QUS and texture parameters to classify periodontal inflammation. The
proposed research will provide novel insights into diagnostic values of QUS parameters and texture features for
diagnosing and monitoring periodontal inflammation.

Public health relevance
Project Narrative Periodontal diseases, affecting 42% of adults in the U.S., impose large economic cost, added pain and systematic health issues on patients that negatively impact their quality of life. The standard diagnostic method for these inflammatory diseases is currently bleeding on probing, which is invasive, only semi-quantitative, and subjective. This study aims at developing a non-invasive and objectively quantitative biomarker based on ultrasonography and a machine learning classifier for periodontal inflammation monitoring by use of an overarching multiparametric investigation.